COVID-19 Telehealth Policies' Impact on Provision of Alcohol and Substance Use Disorder Services at Federally Qualified Health Centers

ABSTRACT
In the United States, alcohol and substance use disorders (AUD and SUD) are highly prevalent and are
established causes of mortality, morbidity, individual and societal costs. There is significant unmet need in
accessible AUD and SUD treatment options, however telehealth is demonstrated to be an effective solution to
addressing barriers to treatment, especially for underserved populations. The COVID-19 pandemic necessitated
a rapid pivot to telehealth by adapting available technologies and deregulating telehealth use as a replacement
to in-person services. Adoption of telehealth for AUD and SUD treatment may be particularly advantageous for
addressing issues of access for medically underserved populations, such as those served by Federally Qualified
Health Centers (FQHCs). Results will identify telehealth policies (i.e., Audio-only Telehealth, Provider Type
Expansion, Service Type Expansion) that were effective during the pandemic to inform lasting changes to health
systems improving access to AUD and SUD services. The central hypothesis is that policies supporting
telehealth during COVID-19 will be positively associated with increased AUD and SUD service utilization in
underserved populations. Our specific aims are as follows: 1. Conduct legal analysis of state Medicaid COVID-
19 telehealth policies; 2. Evaluate state Medicaid telehealth policies on AUD and SUD service utilization at
FQHCs, and 3. Analyze impact of state Medicaid COVID-19 telehealth policies on FQHC special populations.
The study will employ the Center for Connected Health Policy's Policy Finder resource for COVID-19 telehealth
policy data and FQHC program data for outcome data on patient characteristics (e.g., demographic information)
and services provided (e.g., number of visits and number of patients for AUD and SUD services). We will conduct
a series of differences-in-differences models and use other analytic methods using longitudinal data to compare
categorized telehealth policies developed through legal research on state Medicaid telehealth policies. The aims
of the proposed study are inherently innovative as the telehealth policy changes resulting from the COVID-19
pandemic are novel and present a unique opportunity to evaluate the impact of telehealth on AUD and SUD
access and utilization, particularly for underserved populations. Identifying policies that improve access to AUD
and SUD care and treatment will have lasting and significant implications for health services after the pandemic,
such as permanent policy adoption or application to different payors, settings, and populations.

Public health relevance
PROJECT NARRATIVE COVID-19 and necessitated state Medicaid telehealth policies impacting alcohol and substance use disorder treatment delivery provide an opportunity to use varying policy interventions across all states as a natural experiment to investigate the impact of telehealth service expansion on AUD and SUD service utilization. The proposed study aims to evaluate state Medicaid telehealth policies on AUD and SUD treatment use of medically underserved Federally Qualified Health Centers patient populations. Thus, the proposed research is relevant to the NIAAA and NIDA's goals to improve existing behavioral treatments for alcohol and substance use.